Pediatric Neurointensive Care and Resuscitation Research

Neurocritical care (NCC) is the final frontier in pediatric critical care medicine (PCCM). The most common
cause of death in infants and children admitted to a pediatric intensive care unit (PICU) is neurological system
failure and the prevalence of neuromorbidities causing cognitive impairment and reducing quality of life
remains unacceptably high. This T32 research training program “Pediatric Neurointensive Care and
Resuscitation Research,” established in 2000, represents a unique national program. It trains MDs, PhDs, and
MD/PhDs in basic, translational, or clinical research, from seven departments that treat infants and children
who require NCC across the continuum of care, from the field to the emergency department, the PICU, and to
rehabilitation and recovery. Our Specific Aim is to mentor clinicians, specifically fellows in PCCM, Child
Neurology, Neurosurgery, PM&R, Emergency Medicine, Newborn Medicine and Radiology along with
postdoctoral PhD scientists, in research training focused predominantly around two insults, traumatic brain
injury and cardiac arrest. Those two conditions are the leading contributors to pediatric NCC in the developed
world. We feature the unique and formidable resources of the Safar Center for Resuscitation Research and the
University of Pittsburgh Medical Center Children’s Hospital of Pittsburgh in the University of Pittsburgh School
of Medicine to create a highly collaborative, multi-disciplinary and multi-departmental culture for research
training. Our program has a carefully orchestrated research training infrastructure that has been further refined
to include three focus tracks (basic, translational, and clinical science), each with shared and unique
components. It features a choice of cutting-edge projects from 24 nationally recognized mentors, and offers
opportunities to obtain advanced degrees or take targeted courses to enhance career development. In this
outstanding environment trainees work to attain five goals 1) an education grounded in the sound principles of
contemporary neuroscience, 2) that they become academic clinician-scientists or scientists, 3) that they go on
to obtain independent funding, 4) that they ultimately become leaders in the field, and 5) that they are fully
equipped to rigorously and ethically study and successfully develop novel neuroprotective, resuscitative, and
regenerative therapies, and improve neuro-outcomes across all of pediatric NCC. Trainees are supported for
two or three years. Those targeted for faculty positions in Pittsburgh write K award applications. However,
given the National need for trained investigators in pediatric NCC research, our T32 is not designed simply to
create local talent. Our trainees have not only developed into independently funded investigators in Pittsburgh,
but have become National leaders in the field, independently funded investigators at other centers, site PIs for
NIH-funded trials, directors of NCC programs, and promoted and/or Endowed faculty. Our success is also
highlighted by our nine junior faculty “Future Mentors,” who are funded by R21 or K awards and serve as
outstanding exemplars of success in our field, to help guide our new trainees.

Public health relevance
The most common cause of death in infants and children admitted to a pediatric intensive care unit (PICU) is neurological system failure and the survivors suffer life-long neuro-morbidities. Our unique program trains MDs, PhDs, and MD/PhDs in basic, translational, or clinical research, from seven departments that treat infants and children who require neurocritical care across the continuum of care, from the field to the emergency department, the PICU, and to rehabilitation and recovery. The goal of our program is that our graduates ultimately develop into independent investigators who are fully equipped to bring their expertise to rigorously and ethically study and successfully develop novel neuroprotective, resuscitative, and regenerative therapies, and improve neuro-outcomes across all of pediatric neurocritical care.